Research Education Component (REC)

REC PROJECT SUMMARY
The goal of the Research Education Component (REC) of the Pittsburgh Older Americans
Independence Center (OAIC) is to create a new generation of investigators with expertise in age-related
mobility and balance research. These investigators will have expertise in basic, clinical, and translational
approaches and will lead and participate in collaborative multidisciplinary projects. To accomplish this goal, the
REC uses a wide range of learning strategies for trainees. The program integrates training in basic and clinical
research, creates a structured but flexible and rich learning environment, and provides core competencies,
self-assessment tools, research project support, and access to a talented source of senior investigators from
multiple disciplines who are dedicated to mobility and balance research and mentoring.
Our specific aims are to: 1) Promote careers in mobility, balance, and aging research among junior
investigators at 3 levels: Novice investigators (mentees in the initial level of training), Pepper Scholars (junior
faculty with some expertise who receive OAIC salary support), and Transition to Independence investigators
(mentees with independent career development awards). 2) Provide structured career development through
mentored multidisciplinary research experiences, retreats, and career development seminars, as well as formal
didactic programs on basic and clinical research skills through the Clinical and Translational Science Institute
(CTSI) training programs. 3) Promote translational research and cross-training between clinical and basic
science investigators. 4) Coordinate access to a large group of experienced mentors. 5) Offer Scholars a two-
semester grant writing course that enables them to emerge with a polished career development award
proposal or “R” application that is suitable for submission. 6) Provide financial support for trainees through
stipends, pilot funds, and additional resources. 7) Provide individualized advice, feedback, career guidance,
and support to trainees and mentors. 8) Oversee the promotion, recruitment, selection, monitoring, and
evaluation of trainees and the program. 9) Collaborate with other cores and units within and outside the
institution for OAIC related themes. 10) Enrich Scholar training through participation in the OAIC Coordinating
Center's Visiting Scholar Program.
Innovations for this cycle include: (1) a mentoring team for each Scholar that now includes both basic
and clinical researchers, designed to promote team science; (2) a “cross-training” curriculum for all Scholars in
clinical, translational, and basic science; (3) expansion of our Leadership Skills Training curriculum which
focuses on skills critical for emerging leaders; (4) improvement of OAIC mentoring skills through participation in
the NIH/CTSI-funded mentor skills program; and (5) participation in the new OAIC Coordinating Center's
Visiting Scholars Program to provide further training opportunities and support for Scholars' development.